Advancing Nanodiamond Particles for Quantum Sensing

Abstract
This supplement for Technical and Business Assistance (TABA) will help generate sales of products developed
under the parent SBIR grant to support goals of the award. The goal of the parent phase I SBIR grant is to
produce novel functionalized diamond material with enhanced quantum properties. The primary goal of this TABA
supplement is to generate and accelerate sales of the materials developed by the parent grant by implementing
a customer engagement strategy. This will be accomplished through customer exploration by managing
customer outreach in addition to optimizing website content to reach relevant users. Collectively this is expected
to accelerate adoption of the materials developed by this award.

Public health relevance
Narrative This supplement for Technical and Business Assistance (TABA) will help generate sales of products developed under the parent grant to support goals of the award, whch was as follows: single-molecule fluorescent live-cell imaging is a leading technology in fundamental and translational biology correlating individual protein function with biological outcomes. Ultrasmall fluorescent nanodiamond quantum sensors will be developed for advanced single-molecule studies by chemical stabilization of sensing centers within these particles through plasma-based modification enabling sensing of local electromagnetic fields, free radicals, temperature, pH, and conformational dynamics of proteins with nanoscale resolution.